Lifestyle Physical Activity and Cognitive Training Interventions: Preventing Memory Loss in Older Women with Cardiovascular Disease

Project Summary/Abstract
The long-term goal of this program of research is to create and implement multimodal biobehavioral
interventions that will prevent or delay memory loss in older adults but will initially focus on women with
cardiovascular disease (CVD) due to their disproportionately higher risk. This is important as the prevalence of
cognitive dysfunction steeply increases with age after 65 years, affecting women more than men, with greater
severity and more rapid decline. A leading risk factor for cognitive dysfunction is CVD, and loss of memory is
an early-emerging and particularly distressing type of cognitive dysfunction with serious public health
consequences. Evidence shows that both physical activity interventions and cognitive training improve memory
in healthy older adults and may synergize when combined in a multimodal intervention as each targets
different mechanisms. To date, no study testing physical activity interventions and/or cognitive training has
targeted older women with CVD despite their disproportionate risk for memory loss. Moreover, existing
physical activity interventions that target memory are largely supervised and structured, which can fail to
generate long-term behavior change. In contrast, lifestyle approaches emphasizing small behavioral changes
to daily life are more likely to be maintained. Older women and adults with CVD prefer lifestyle interventions in
the home and community over structured exercise interventions in a gym or lab. Finally, few combined
interventions have included serum biomarkers (e.g., brain-derived neurotrophic factor [BDNF], vascular
endothelial growth factor [VEGF], insulin-like growth factor 1 [IGF-1]) that may be early indicators of
intervention effects. We will build upon the promising findings of our two lines of research: (1) a lifestyle
physical activity intervention targeting older women with CVD, and (2) easily disseminated cognitive training
with the BrainHQ program in patients with heart failure. The next step of this research program is to analyze
the independent and combined effects of a lifestyle physical activity intervention (Move) and cognitive training
(Mind) on memory in women ≥ 65 years with CVD. In the proposed study, we will evaluate the efficacy of the
24-week combined MindMoves on memory performance and memory-related serum biomarkers at 24, 48, and
72 weeks in older women with CVD. Using a 2x2 factorial design, 254 older women with CVD will be recruited
from two women’s cardiology clinics and randomized to one of four conditions: (1) Move, (2) Mind, (3)
MindMoves, (4) usual care control. Aims are to: (1) determine the independent and combined efficacies of
Move and Mind interventions on memory performance, (2) determine the independent and combined efficacies
of Move and Mind interventions on memory-related serum biomarkers (BDNF, VEGF, IGF-1), and (3) examine
depressive symptoms and genetic factors (APOE-ε4 allele, BDNF genotype) as potential moderators of the
association between changes in target behaviors and memory. Findings will provide key knowledge about the
ability of practical and scalable multimodal lifestyle interventions to target memory in older women with CVD.

Public health relevance
Public Health Relevance/Project Narrative Older women with cardiovascular disease (CVD) are at greater risk for memory loss, an important public health issue due to the negative effects to quality of life and health care costs. This research will be the first to examine the independent and combined effects of a lifestyle physical activity intervention and cognitive training on memory performance and memory-related serum biomarkers in this vulnerable population. We will incorporate a practical and scalable lifestyle approach that can be delivered in the home and community settings to prevent or delay memory loss in older women with CVD.